Leadership Administrative Core

The purpose of the Leadership Administrative Core is to provide the overall interdisciplinary and
translational scientific planning and coordination for the Yale-SCORE, as it develops sex-appropriate
therapeutics for the treatment of alcohol use disorders (AUD) using the ‘dark side of addiction’ as a guiding
framework. Specifically the Core, through its structure and resources, will: 1) manage the ongoing conceptual
integration of Center personnel to capitalize on the synergies and translational opportunities of the Yale-
SCORE, 2) support the development of new collaborative research within the Yale-SCORE and with other Yale
Centers and SCOREs at other institutions, 3) organize regular planning meetings to promote dynamic
exchange among investigators regarding new scientific findings and their implications for sex-appropriate
medications development, 4) facilitate the work of the Projects, Pilots, and Cores through fiscal and
administrative oversight, solicit, review and fund meritorious Pilot Projects, oversee the distribution of research-
related resources; provide input into the design of a core battery, and the collection of biosensor data to
maximize the scientific yield of the Center, and 5) educate and inform our communities and function as an
institutional, regional, and national resource to invigorate the study of sex and alcohol use. Our approach is
designed to ensure that the Project Leads, investigators, collaborators, and trainees operate in an integrated
scientific environment that creates a coordinated interdisciplinary translational team effort, focused on
advancing the development of sex-appropriate treatment for AUD. The goals of the Core will be accomplished
through the following specific aims. AIM 1: Provide integrated scientific research planning and oversight
among the Yale-SCORE’s Principal Investigator, Deputy Director, and Executive Committee, with targeted
consultation from the External Scientific Advisory Board. AIM 2: Ensure fiscal and administrative oversight to
the Yale-SCORE Projects and Pilot Projects. AIM 3: Be an institutional, regional, and national resource to
invigorate and galvanize the study of sex differences in relation to alcohol use across T1 to T4 translation by
providing expert consultation, supporting faculty training awards, leveraging national data on sex and alcohol
use to inform treatment and policy, and by providing outreach and dissemination to local community, regional,
and national audiences.

Public health relevance
Rates of alcohol use disorders (AUD) in women have increased by 84% over the past 10 years. All FDA- approved medications for AUD have relatively low efficacy and none target factors that maintain drinking in women. The Leadership Administrative Core will advance the public health effort to improve AUD treatment by providing key infrastructure to support an integrated scientific environment focused on the development of sex- appropriate treatments for AUD.